MAGNETIC RESONANCE IMAGING OF THE NEUROTRANSMITTER GABA AND GLUTAMATE IN VIVO

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Gamma-aminobutyric acid (GABA) and Glutamate are the two major neurotransmitters of the brain. Their levels are also altered by disorders of the central nervous system (CNS) and several drugs acting on the central nervous system (CNS) mediate their effects by changing GABA and Glutamate levels. Hence, GABA and Glutamate serve as surrogate markers for diagnosis, treatment, and evaluation of therapeutic efficacy. Existing approaches for measuring regional changes in GABA and Glutamate in humans include positron emission tomography (PET), single photon emission tomography (SPECT) and Magnetic Resonance Spectroscopy (MRS). The shortcomings of PET and SPECT are low resolution and radiation exposure, which limits applicability to functional studies. MRS on the other hand is able to detect GABA and Glutamate in-vivo, but requires complicated spectral editing techniques and has limited spatial and temporal resolution. In this project, we are developing a novel, noninvasive, nonradioactive and high resolution approach for imaging brain GABA and Glutamate exploiting chemical exchange saturation transfer (CEST) effect from the amine proton groups on GABA and glutamate.